SODIUM PUMP, INTRACELLULAR NA AND TENSION IN HEART

The proposed research project will examine how the function of cardiac muscle depends on the transport of ions across the plasma membrane of heart muscle cells. It will also investigate how the intracellular ion activity of Na+(aNa), of Ca++(aCa) and of H+(pHi) influence the electrical and mechanical behavior of the heart. The planned work will use isolated sheep cardiac Purkinje fibers and a two-microelectrode voltage-clamp technique. Tension, membrane current, aCa, aNa and pHi will be measured during voltage-clamp control of the membrane potential. Using ion-selective microelectrodes, two cation activities will be recorded continuously in each experiment. These techniques permit experimentally imposed control of many critical factors in addition to membrane potential. The intracellular activity of each of the ions we are studying can be altered independently by adjusting the composition of the extracellular solution and the turnover rate of the Na pump. Fine adjustment of the intracellular ion activities is also possible because we will be measuring them and because we can adjust the extracellular solution as needed. Furthermore, we can modify independently the activity of the two transport systems that regulate aCa and aNa. The Na-Ca exchange can be inhibited by removing all extracellular Na from the superfusing solution. All ATPi-dependent calcium regulatory systems can be inhibited by use of metabolic blockers (e.g. FCCP, Azide). Specific experiments will address the following questions: (1). What is the relative importance of the Na-Ca exchange mechanism versus ATP-dependent a Ca-regulatory systems in controlling aCa? (2). What are the quantitative relationships between tension and aCa? How are these relationships altered by pHi, aNa or drug application (e.g. lidocaine, strophanthidin)? (3) What are the ionic mechanisms that regulate the magnitude of the slow inward "calcium" current (Isi) in heart? How does Isi contribute to cardiac calcium metabolism? (4). How do antiarrhythmic agents (e.g. lidocaine) act? The proposed research should broaden our understanding of the mechanisms that control the intracellular ion composition of heart muscle and increase our knowledge of the roles intracellular ions play in regulating cardiac function. This work will therefore provide insight into the cellular mechanism that control: a. the heartbeat and arrhythmias; b. the inotropic state of the heart; and c. drug therapies that alter a and b.